SUPPORT FOR THE NCI DCCPS HEALTHCARE DELIVERY RESEARCH PROGRAM FOR THE NCORP ANNUAL MEETING.

THE CONTRACTOR SHALL SUPPORT THE DCCPS HEALTHCARE DELIVERY RESEARCH PROGRAM FOR THE NCORP ANNUAL MEETING. THIS MEETING IS BEING PLANNED AS AN IN-PERSON MEETING; PLANS ARE IN PLACE HOWEVER, SHOULD THE NCI NEED TO CONVERT TO VIRTUAL.